Breathing Research and Therapeutics (BREATHE)

We propose renewal of the Breathing Research and Therapeutics (BREATHE) Training Program at the University of Florida (UF). This combined predoctoral and postdoctoral training program, which began in 2017, is focused on the respiratory neuromuscular system, emphasizing discovery of new knowledge and its translation to severe clinical disorders that compromise breathing capacity, stability and airway defense. In just over 4 years, with a “ramp-up” of 2 years, we established an internationally known training program with a “unique focus, unlike any other” (quote from anonymous NIH reviewer); we are unaware of any other T32 with a similar concentration on breathing and airway defense in traumatic, ischemic, infectious or degenerative clinical disorders. Nine predoctoral and 7 postdoctoral trainees have been funded through the BREATHE training program; all graduates have continued in academic, biomedical or research positions. In this renewal, we will continue building and refining this unique program, with the goal of training the next generation of scientists devoted to preserving and restoring breathing and airway defense in clinical disorders that most often end life by respiratory failure. Our intent is to establish a cohort of respiratory scientists capable of engaging in basic discovery and clinical/translational research. BREATHE emphasizes training in respiratory neural and muscle plasticity, and development of new therapeutic strategies to treat patients with compromised breathing capacity, stability and/or airway defense. Our objectives are: 1) recruit a cohort of high-quality basic science and clinical predoctoral and postdoctoral candidates with an interest in breathing research and therapeutics, and the potential for long-term success as independent investigators; 2) implement a carefully designed training program that provides predoctoral and postdoctoral trainees with solid foundations in respiratory biology, airway defense and translational research, and the technical, analytical and professional skills necessary for productive research careers; and 3) foster a collaborative research environment conducive to preparing scientists for successful careers in interdisciplinary research. The UF environment includes collaborative faculty mentors with varied yet complementary expertise, state-of-the-art facilities, ongoing translational research partnerships and a rich menu of career development opportunities. Our renewal application builds on proven elements, with an emphasis on being responsive to the rapidly changing landscape of respiratory research.

Public health relevance
Although diminished breathing capacity and airway defense undermine the quality and duration of life in virtually all neuromuscular disorders, such as spinal injury, ALS, Pompe disease, muscular dystrophy and Parkinson’s disease, few biomedical researchers have the expertise and translational perspective needed to develop new treatments that preserve or restore the ability to breathe and defend the airway. This renewal application seeks continued funding to train pre- and postdoctoral fellows with basic science, clinical or engineering backgrounds to fill this critical need. Trainees will develop a solid foundation in the respiratory biology, airway defense, translational research and technical/analytical skills needed for productive careers in breathing research and therapeutics.